Role of the Na K ATPase Beta 1 subunit in alveolar epithelial integrity

DESCRIPTION (provided by applicant): Lung edema is a life-threatening complication of lung injury. The active transepithelial Na+ ion transport performed in part by the alveolar epithelial Na,K-ATPase is critical for lung edema clearance. Edema impairs gas exchange, which leads to alveolar hypoxia. Hypoxia, in turn, impairs intercellular adhesion and decreases the amount of the Na,K-ATPase at the plasma membrane, worsening clinical outcomes. The minimal functional unit of the Na,K-ATPase is a dimer consisting of an α and a β subunit, which not only transports ions, but also acts as a cell adhesion molecule. FXYD5 is a one of the 7 tissue-specific regulatory subunits of the Na,K- ATPase activity, which is also implicated in the impairment of intercellular junctions. In preliminary experiments, we observed that hypoxia impairs intercellular adhesion and up-regulates FXYD5 in alveolar epithelial cells. We hypothesize that the Na,K-ATPase is important for modulating the integrity of the alveolar epithelium by strengthening cell-cell contacts due to the interaction between the Na,K-ATPase β1 subunits of neighboring alveolar epithelial cells and by weakening these contacts by FXYD5- mediated impairment of β1:β1 bridges during hypoxia. In specific aim # 1, we will determine whether the interactions between the Na,K-ATPase β1 subunits of neighboring alveolar epithelial cells are impaired by hypoxia We will determine whether modulating β1:β1 interactions by removing N-glycans or modifying their structure alters cell-cell adhesion during normoxic and hypoxic conditions in vitro or in vivo. In specific aim #2, we will determine whether FXYD5 up-regulation during hypoxia impairs β1:β1 interactions. By over-expressing or silencing of FXYD5 in lung epithelial cells, in both normal and hypoxic conditions, we will determine whether FXYD5 contributes to hypoxia-induced impairment of intercellular adhesion by disrupting the interaction between the Na,K-ATPase ? subunits of neighboring cells in vitro or in vivo. In specific aim #3, we will investigate chaperone-assisted maturation pathways of the Na,K-ATPase in the endoplasmic reticulum (ER) of alveolar epithelial cells in normal conditions and during hypoxia. In experiments performed for this proposal, we observed that hypoxia results in significant retention of the Na,K-ATPase in the ER of alveolar epithelial cells and thus decreases its abundance in the plasma membrane, which would impair edema fluid clearance and barrier function. We will determine whether up-regulation of ER chaperones by N-glycan processing inhibitor, castanospermine, rescues the maturation of the Na,K-ATPase and whether application of this inhibitor prior to exposure of mice to hypoxia improves barrier function. The proposed studies will provide insights into non- canonical roles of the Na,K-ATPase in stabilization of cell cell contacts, which are crucial for normal function of alveolar epithelia. Understanding the mechanism(s) underlying chaperone-assisted maturation of the Na,K- ATPase in alveolar epithelial cells and finding the means to prevent ER retention of the enzyme during hypoxia may lead to more effective treatment for pulmonary edema and acute lung injury.

Public health relevance
PUBLIC HEALTH RELEVANCE: The active transport of sodium ions performed by alveolar sodium-potassium ATPase is crucial for resolution of lung edema, which is a life-threatening complication of acute lung injury. The sodium pump not only regulates the function of the alveolar epithelium by pumping sodium ions but its subunits form bridges between neighboring cells which are important for the permeability and integrity of the alveoli. This study will look a specific changes in the formation of these bridges, and thus the function of the epithelia, when the cells are exposed to stimuli that modify the amount of the pump at the plasma membrane or by the presence/absence of different molecular partners.